Population Based Research in Geriatric Palliative Care

Aging represents one of the largest public health challenges in our history. By 2030, 20 percent of the U.S.
population will be over age 65, the group at highest actuarial risk of cancer, heart disease, dementia, and other
chronic, complex illnesses. Geriatric palliative care is interdisciplinary care that focuses on providing relief from
the symptoms and stress of serious illness with the goal of improving quality of life for older adults and families.
Extensive national data demonstrate a high prevalence of physical, psychosocial, and financial suffering
associated with serious illness; stress and burden related to caregiving for the more than 35 million individuals
serving as informal caregivers to the seriously ill; and a healthcare system that fails to deliver appropriate and
timely care to older adults with serious illness and their families.
To address these issues, researchers have turned to an increasing number of large, population based
survey and administrative datasets to answer pertinent questions in the field of geriatric palliative care. These
large datasets have become essential to understanding how social factors, health policies, financing systems,
organizational structures and processes, social networks, and personal behaviors affect patient and caregiver
outcomes, access to healthcare, quality and cost of healthcare, and patterns of healthcare over time and
across vulnerable subgroups. Single site and small multi-site studies are often unable to enroll a large enough
sample to study individuals with a wide range of diagnoses, comorbid conditions, and functional limitations or
to collect information on social determinants of health due to budgetary and time constraints of primary data
collection. Existing population based studies, however, provide the opportunity to rapidly influence both policy
and clinical practice in geriatric palliative care. Yet, the methodological challenges of this type of observational
research are substantial including complex longitudinal data, hierarchical structures, informatively missing data
due to death or dropout, proxy respondents, and complex survey-weighted designs.
It is thus imperative to build a research program that attracts, trains, and supports a sustainable pool of
geriatric palliative care investigators for ongoing, rigorously conducted, population based research. As such,
Dr. Aldridge is seeking an Academic Leadership Career Award to develop a Population Based Research
Program in Geriatric Palliative Care at Mount Sinai. This Program will train geriatric palliative care
researchers to apply sophisticated research and statistical methodology used in other fields but not commonly
applied to geriatric palliative care research, and develop sustainable research infrastructure to support new
generations of researchers across faculty, fellows, residents, and medical students interested in population
based research. Dr. Aldridge has been at the forefront of training and dissemination of research methods for
observational data. As newly appointed Vice-Chair for Research and with more than a decade of experience
utilizing these types of data, Dr. Aldridge is uniquely qualified to successfully achieve the aims of this award.

Public health relevance
Aging represents one of the largest public health challenges in our history. Population based data provide the opportunity to examine the complex issues in geriatric palliative care and to rapidly influence both policy and clinical practice, yet the methodological challenges of this type of observational research are substantial. The proposed Population Based Research Program in Geriatric Palliative Care at Mount Sinai will train and support new generations of geriatric palliative care investigators for rigorously conducted, population based research at the intersection of geriatrics and palliative care.